DNA helicases and associated factors in genome stability

PROJECT SUMMARY
DNA helicases function in virtually all aspects of DNA replication, recombination, and repair. As such,
they are vital to maintaining genome integrity and are disease linked when mutated. Despite many in vivo and
in vitro advances in working with helicases, there is a gap in knowledge connecting mutant alleles of helicase
genes to the treatment of patients in clinics. The objective of my research is to gain mechanistic insight into
how DNA helicases function in genome maintenance and why their dysfunction leads to disease. Toward this
goal, we are studying PIF1 and RecQ family helicases, which are evolutionarily conserved and because
mutations in the human genes encoding these helicases are associated with multiple diseases. Our current
work focuses on the roles of RecQ helicases in DNA inter-strand crosslink (ICL) repair and RecQ and Pif1
helicases in telomere maintenance. To perform this work, we will employ a variety of classic and cutting edge
experimental techniques, from standard in vitro enzymatic assays and model organism genetics to next-
generation sequencing, crosslinking mass spectrometry, and the development of custom click chemistry
probes. Overall, this work will provide fundamental data critical to understanding how PIF1 and RecQ family
helicases aid in the maintenance of genome stability, and it will ultimately lead to therapeutic targets and
treatments for helicase-linked diseases.
In this application, I am requesting funds to support a 10-week research experience for Ms. Morgan
Roush in my lab during the summer of 2023. The purpose of this project is to enable Ms. Roush to gain
research experience in molecular biology and yeast genetics to support her goals to pursue a career in
biomedical research. Ms. Roush’s research project will examine the link between G-quadruplex (G4) DNA
stability and genome integrity. Ms. Roush aims to generate Saccharomyces cerevisiae strains lacking the
enzymatic activity of one or more DNA helicases implicated in G4 structure unwinding and maintenance. She
will then test the effects of over-expressing a G4-binding and -stabilizing nanobody in these strains to compare
the toxicity of G4 stabilization to wild-type cells containing a full complement of helicases. Ms. Roush will
attend and present at our weekly group meeting, and she will present a poster in the Indiana University
Undergraduate Research Symposium at the end of summer 2023. It is my further hope that her summer
research experience is positive and that she will remain a productive member of my lab until she graduates.

Public health relevance
PROJECT NARRATIVE My lab studies the disease-linked PIF1 and RecQ family helicases, which are vital to the maintenance of genome integrity, using a variety of experimental approaches and model systems. We will determine the mechanistic roles of these helicases in DNA repair and telomere maintenance, as well as the functional consequences of genetic and physical interactions between RecQ4s and other helicases. In this supplement proposal, I am requesting funds to support a summer undergraduate research experience for Morgan Roush, a Molecular Life Sciences major at Indiana University.